DYnamics of Contraception in Eswatini (DYCE)

PROJECT SUMMARY/ABSTRACT
The five-year training and research project outlined in this application will foster the career of Dr. Abigail
Greenleaf, an already accomplished scholar in cell phone-based cross-sectional data collection in sub-Saharan
Africa to master high-frequency, longitudinal sexual and reproductive health studies. With the proposed career
development and research activities, the candidate will be poised to make significant contributions in the field of
international sexual and reproductive population studies. This Mentored Research Scientist Development award
is designed to meet Dr. Greenleaf’s near-term career development goal of understanding contraceptive
dynamics – adoption, continuation, discontinuation, and switching – among adolescent girls and young women
in a high HIV prevalence setting (Eswatini), and to meet her overarching career goal to become an independent
scholar who advances knowledge of sexual and reproductive health. Thus, the K01 research will be supported
by mentor-guided career development training in four complementary areas to facilitate her long-term research
goals. To enrich her reproductive health scholarship, Dr. Greenleaf will be (1) trained in sociology theories of
pregnancy desire. To (2) analyze high-frequency longitudinal data, she requires skills in advanced statistical
methods. She will (3) gain expertise in prevention and risk of HIV acquisition. Finally, to become an independent
NIH-funded investigator, Dr. Greenleaf will (4) undertake professional development activities. This innovative
proposal aligns with a key scientific priority of NICHD Population Dynamics Branch: studying contraceptive use
and non-use. The research plan has three aims: (1) Investigate how changing states (schooling, income,
residential mobility) impact contraceptive use; (2) Examine the relationship between pregnancy desires and
contraceptive use; (3) Test whether changes in a woman’s perception of her HIV risk changes her probability of
contraceptive use and HIV prevention behaviors. Career development and research activities will be supervised
by a team of mentors including primary mentor Dr. Elaine Abrams, Professor of Epidemiology and Pediatrics at
Columbia University and two co-mentors: Dr. Jennifer Barber, Sociology Professor, Indiana University; and Dr.
John Santelli, Professor, Heilbrunn Department of Population and Family Health and Pediatrics at Columbia
University. The proposed K01 project will place Dr. Greenleaf in a unique and important position to conduct truly
innovative studies of contraceptive and HIV-prevention behavior among adolescent girls and young women in
Sub-Saharan Africa, a priority population for reaching global sexual and reproductive health improvements.

Public health relevance
PROJECT NARRATIVE Adolescent girls and young women in sub-Saharan Africa have the highest rate of undesired pregnancies and HIV incidence (relative to other ages) but little is known about the dynamics of contraceptive use and of HIV-prevention behaviors among this vulnerable age group because face-to-face data collection (the predominate data collection approach in sub-Saharan Africa) is too expensive and time-consuming to collect repeated measures. Therefore, the impact of changing states (income, schooling, residential mobility) on contraceptive use and pregnancy desire, as well as how HIV risk perception changes contraceptive behaviors is understudied. Using cell phones to collect high frequency, longitudinal data is an innovative approach that will lead to new insights about the circumstances surrounding adolescent girls and young women’s sexual and reproductive health, creating actionable data for increased reproductive autonomy.